Core B: Outreach, Ascertainment, and Data Collection

PROJECT SUMMARY/ABSTRACT: CORE B (Outreach, Ascertainment and Data Collection Core)
The overall goal of Core B is to provide the infrastructure and support for the ascertainment and collection of
phenotypic data and biological samples on 4000 African Americans (AA), 4000 Hispanic/Latinx Americans (HL)
and 5000 Africans (AF) from the US and Africa. The phenotypic data gathered by Core B will sent to Core E
and used for adjudication and harmonization by Core C, while the blood, plasma, and RNA samples collected
by Core B will be sent to the John P. Hussman Institute for Human Genomics (HIHG) at the University of Miami
(UM), used for DNA genotyping for Projects 1 and 2 and future WGS studies in FUS 2.0 and biomarkers and
expression studies (Core D). The work of Core B will provide the necessary materials for both common and rare
variant analysis and discovery in ancestral populations in the imputation studies in Projects 1 and 2. Specific
Aim 1 will recruit and ascertain AA and HL participants in four US and nine AF sites. The AF sites are in eight
different countries, all members of the African Dementia Consortium (AfDC). The University of Ibadan, Nigeria,
will be the primary coordinating site for the other AfDC sites. We will ascertain ~13,000 individuals/participants
(6,500 cases and 6,500 controls) consisting of AA (n=4,000), HL (n=4,000) and AF (n=5,000). Specific Aim 2.
We will collect clinical, neurocognitive testing, blood samples and metadata on AA (n=4,000), HL (n=4,000) and
AF (n=5,000) participants. Tubes for DNA, RNA and plasma will be collected. This study will provide a resource
for future studies in AD in AA, AF and HL patients.